Amyloid Beta and Collagen IV Interactions in the Brain Microvasculature in Alzheimers Disease

Abstract/Summary
Microvascular (MV) changes occur early in the Alzheimer’s disease (AD) brain. Loss of MV basement
membrane (BM) integrity due to alterations in Collagen IV (Col IV), a major component of BM, in particular
predisposes the MV to complications such as microhemorrhages. In the MV of both AD and the related condition
of congophilic amyloid angiopathy (CAA), levels of Col IV vary and deposition of amyloid beta (Ab) is in close
spatial proximity, but specific interactions between Col IV and Ab are not known. Notably, we recently found that
the Ab binding antibody, lecanemab (BAN2401), causes degradation of MV Col IV. Thus, we hypothesize that
Ab deposition induces structural and/or enzymatic processes that result in MV BM Col IV destabilization,
and that subsequent removal of Ab by lecanemab results in Col IV breakdown, causing MV dysfunction.
Brain Col IV is restricted to the vascular BM, and requires models that retain native Col IV and Ab to advance
understanding of MV extracellular matrix (ECM). We propose 3 feasible aims to elucidate the interactions of Ab
and Col IV in AD. Since little is known about the associations of Ab and Col IV in AD, Aim 1 will define the
ultrastructural/spatial relationships among Ab, Col IV, and mediators of Col IV degradation in MV of AD/CAA and
control brain sections, and in matched viable human brain MV (huMV). Aim 2 will use the 5xFAD mouse model
of MV Ab to determine if/how Ab deposition, and subsequent Ab removal, affects Col IV and subsequent MV
function in a mouse model of microvascular Ab. Aim 3 leverages a unique repository of viable human brain MV
from AD/CAA and controls to define how modifying Ab by 2 different methods: the Ab binding antibody,
lecanemab, and breaker peptides, a small molecule non-antibody mediated method of removing Ab, effects
changes in Col IV and the neurovascular unit (NVU).
Impact: Completion of this project will advance the understanding of brain MV Col IV interactions with Aβ that
are likely important in mediating MV dysfunction in the context of AD/CAA progression. In addition, our project
offers mechanistic insight on the adverse effects of Aβ-lowering therapies, which is needed for advancements
to improve their safety.

Public health relevance
Narrative Deposition of Amyloid beta (Ab) affects the microvasculature (MV) in Alzheimer’s disease and the related condition of Congophilic Amyloid Angiopathy (CAA). One sequelae of this deposition in or near the MV is alteration in collagen IV (Col IV), the primary structural protein in the MV basement membrane (BM). This proposal will examine the effect of Ab deposition on Col IV stability during disease progression in human and mouse models, and will define how different methods of removal of Ab could degrade Col IV and the MV BM leading to clinically significant damage such as MV disruption and microhemorrhage.